Cluster randomized trial of a mobile health intervention to achieve appropriate gestational weight gain in overweight/obese women

Excessive gestational weight gain (GWG), defined as GWG above the current Institute of Medicine (IOM)
GWG guidelines is associated with adverse short and long-term health complications for women and their
infants. Overweight and obese women are at already at high risk of complications due to their elevated weight,
and excessive GWG further exacerbates their high risk of complications. Thus, there is an urgent need to help
reduce excessive GWG in this high-risk population. Traditional high-intensity interventions to improve GWG
among overweight and obese women have achieved success but are too time intensive for some women. In
addition, studies show women consider behavior change advice to be more persuasive if it comes from their
clinician, but clinicians have insufficient training on weight counseling. Thus, interventions aimed at reducing
excess GWG among overweight and obese women that are practical for both women and clinicians are
needed. Emerging evidence and our pilot work suggest that mobile health (mHealth) interventions for weight
management can be effective in pregnancy, but a large-scale randomized trial in the real-world clinical setting
is needed. We will conduct a cluster randomized controlled trial of 56 clinicians (caring for 2040 pregnant
overweight/obese women) randomized to usual care or usual care plus an mHealth intervention. We propose
an adaptive intervention that increases in intensity according to patients’ GWG in relation to the IOM
guidelines. Technology-based tools—including a mobile app, wireless “smart” scale, wearable activity tracker,
and diet tracking app—will enable convenient self-monitoring, feedback, and goal setting. These tools will
provide largely automated, real-time feedback to patients via text messaging and will transmit real-time GWG,
physical activity and diet data to a lifestyle coach and obstetric clinician. All patients of clinicians in the
intervention, receive the technology-based tools, automated text messages and weekly e-mails of core lifestyle
intervention sessions (Step 1). Step 2 is the addition of personalized text messages; and Step 3 is the addition
of personalized 1:1 telephone coaching sessions, with these latter 2 Steps reserved for patients who need
them. Clinicians in the intervention also receive training and tools embedded in the EHR to facilitate discussing
GWG with their patients. Our primary aim is to evaluate whether an adaptive mHealth intervention designed to
help overweight/obese women and their clinicians manage GWG will improve GWG in comparison to usual
care. Our secondary aim will evaluate whether an mHealth intervention improves postpartum weight retention
at 6 weeks, the proportion of infants with appropriate birthweight (<10th and >90th percentile) and infant
growth trajectory from birth to 12 months. We will evaluate the cost-effectiveness of the mHealth intervention
and possible adoption using a RE-AIM framework. If this mHealth intervention is proven effective, it could
become a complementary part of clinical care, leading to better outcomes for mothers and their infants.

Public health relevance
Excess gestational weight gain among overweight and obese pregnant women has adverse health implications for women and their infants. We will test whether a lifestyle intervention, delivered largely via mobile phone, and accessible to both women and their doctors, can help overweight and obese women gain appropriate weight during pregnancy.